LincRNAs in Mucosal Defense to AIDS Opportunistic Pathogen Cryptosporidium

Summary
Cryptosporidium remains a significant AIDS-related opportunistic infection among people with late HIV
diagnosis or without access to HAART. This parasite infects the gastrointestinal (GI) epithelium in humans;
infection is also a common cause of diarrhea in young children in developing countries. There is currently no
fully effective therapy available for the infection. This parasite has been referred as a “minimally invasive”
mucosal pathogen, and epithelial antimicrobial defense is key to mucosal innate anti-Cryptosporidium
immunity. Whereas it is well appreciated that IFN-γ is required for preventing development of intestinal
cryptosporidiosis, the key cellular regulatory elements that determine IFN-γ-mediated GI epithelial anti-
Cryptosporidium defense, as well as its association with the high susceptibility of infection in AIDS patients and
in young children, remain unknown. Our recent studies demonstrate that IFN-γ-mediated epithelial anti-
Cryptosporidium defense requires the induction of specific long intergenic non-coding RNAs (lincRNAs) in
epithelial cells. Specifically, we have identified several lincRNAs that are expressed strictly in epithelial cells.
Expression levels of several epithelial lincRNAs are upregulated in GI epithelial cells following Cryptosporidium
infection. Knockdown of selected epithelial lincRNAs attenuated IFN-γ-mediated epithelial anti-Cryptosporidium
defense. Based on these observations, we hypothesize that induction of epithelial lincRNAs in GI epithelial
cells upon pattern-recognition receptors signaling promotes mucosal anti-Cryptosporidium immunity through
priming epithelial cells for IFN-γ-mediated epithelial antimicrobial defense. We will use in vitro and in vivo
infection models and complementary biochemical, molecular, and morphologic approaches to define the
transcription of epithelial lincRNA genes upon pattern-recognition receptor signaling in GI epithelial cells
following Cryptosporidium infection (Aim 1), elucidate the molecular mechanisms by which epithelial lincRNAs
promote IFN-γ-mediated epithelial anti-cryptosporidial defense (Aim 2), and decipher the roles of specific RNA-
binding proteins in modulating IFN-γ-mediated anti-cryptosporidial defense in GI epithelial cells through their
interactions with epithelial lincRNAs (Aim 3). The proposal is conceptually innovative as it tests new concepts
regarding mucosal antimicrobial defense and the pathogenesis of intestinal cryptosporidiosis, relevant to the
design and implementation of new therapeutic strategies.

Public health relevance
Health Relevance Cryptosporidial infection remains significant in AIDS patients and young children. The proposed research will study the role of epithelial lincRNAs in IFN-γ-mediated GI mucosal immune responses. The overall goal is to elucidate the molecular mechanisms by which epithelial cell-specific lincRNAs coordinate mucosal anti- Cryptosporidium defense and provide a basis for the identification of novel targets for therapeutic intervention.